NEUROTROPHIC ACTIVITY IN CEREBROSPINAL FLUID OF SCHIZOPHRENIC PATIENTS

We tested the ability of CSF from neurologic and psychiatric patients to allow the survival in culture of sympathetic neurons from chicken embryo ganglia. The presence of a neurotrophic activity in the CSF of some schizophrenic patients will be discussed in correlation with neuroleptic treatment or cerebral ventricle enlargement.